Increasing Equity in Live Donor Kidney Transplant through Effective Patient-Provider Communication (EPPCom)

PROJECT SUMMARY
Live donor kidney transplant (LDKT) is the preferred treatment modality for patients with chronic and end-stage
kidney disease. LDKT is less expensive than prolonged dialysis and offers improved mortality and morbidity
over either dialysis or deceased donor kidney transplants (DDKT). However, ethnic minorities have significantly
less access to LDKT than their White counterparts. Collectively, Blacks, Asians, and Hispanics represent
64.3% of the kidney transplant wait list, yet received only 36% of all LDKTs in 2019. Further, rates of LDKTs
have decreased for Black patients over the last decade. Decades of research point to patient-provider
communication as a contributing factor to observed disparities in health and healthcare outcomes. To date,
however, no attempt has been made to gauge the impact of the communication occurring during transplant
evaluation consultations on LDKT outcomes. The long-term goal of the proposed study entitled, Increasing
Equity in Live Donor Kidney Transplant through Effective Patient-Provider Communication, is to increase parity
in access to LDKT for Black patients. We propose a community-engaged, mixed-methods study employing a
concurrent triangulation design to identify the specific communicative behaviors that result in live donor
inquiries and evaluations, and actual LDKTs for Caucasian and Black patients, providing critical information to
the design of an intervention to improve patient-provider communication about LDKT. Specifically, we will
simultaneously quantitatively assess patient and provider factors with established and hypothesized
associations with receipt of LDKTs, and qualitatively assess discrete elements of patient-provider
communication occurring during transplant evaluation consultations for Caucasian and Black patients (Aim 1).
Brief quantitative surveys administered before and after medical consultations held as part of the evaluation for
transplant candidacy will capture providers’ (N=52) confidence and comfort discussing LDKT and patients’
satisfaction with the consultation, medical mistrust, health literacy, and LDKT knowledge, attitudes and
readiness. We will also audiorecord transplant evaluation consultations for 60 Caucasian and 60 Black patients
(N=120) across the two study sites – Saint Barnabas Medical Center (NJ) and Temple University Hospital
(PA), and qualitatively assess the communication occurring during the consultations. We will use the findings
to inform development of the content and format of a communication skills training for transplant providers and
evaluate the direct and indirect effects of the training on patient-reported and LDKT process outcomes (Aims 2
& 3). Intervening at the provider level is both practical, given that all transplant candidates already must
undergo this consultation, and efficient, given that a single transplant physician can evaluate >100 transplant
candidates per year. Thus, the results of this innovative study have the potential to increase access to LDKT
for Black patients currently awaiting kidney transplant. Improving communication during the transplant
consultation may prove to be an effective and efficient means of alleviating ethnic disparities in LDKT.

Public health relevance
PROJECT NARRATIVE Despite years of effort, ethnic disparities in access to live donor kidney transplants – the optimal treatment option for individuals living with chronic and end-stage kidney disease, persist and Black patients continue to have the lowest rates of living donor transplants. This application proposes to explore the instrumental, relational and affective communication occurring between Black and Caucasian patients and their transplant providers during transplant evaluation consultations and assess relationships between these communicative elements and patient and provider factors, patient-reported outcomes and living donor transplant outcomes - living donor referrals, evaluations, and transplants. We will use these findings to inform the development of a communication skills training for transplant providers and test the impact of the training on providers’ communication about live donor kidney transplants with Black and Caucasian patients and living donor transplant outcomes.